Sex chromosome contributions to alcohol drinking behaviors

Project Summary: Men and women have differing vulnerabilities to alcohol. For example, men
develop Alcohol Use Disorder at higher rates but research shows that women may escalate their
drinking faster and be more motivated to resume use following abstinence. Preclinical research in
animals consistently demonstrates higher rates of consumption in females and that gonadal sex,
chromosomal sex, and alcohol exposure interact to influence levels of alcohol intake. In regards
to chromosomal sex and alcohol drinking behaviors, a subset of genes of interest on the X
chromosome are of potential interest because of their ability to escape transcriptional repression
in brain tissues. The central hypothesis driving the proposed studies is that X chromosome
dosage influences alcohol consumption through overexpression of these genes, but that these
effects may depend on gonadal status or alcohol exposure history. Our experiments will test this
hypothesis through completion of three primary aims. We will 1) demonstrate that alcohol
consumption is reduced in mice with two (i.e., XX) vs. one (i.e., XY or XO) copies of the X
chromosome, 2) determine whether a history of alcohol exposure alters expression of genes that
escape X chromosome inactivation in the brain and whether these effects depend on gonadal
status, and 3) identify the candidate gene Gprasp1 as a regulator of alcohol drinking behaviors
via its actions on dopamine receptors. These aims will be achieved through the use of two-bottle
choice alcohol drinking tasks, surgical gonadectomy, quantification of gene expression with RTPCR,
site-specific gene knockdown, and pharmacological antagonism. Collectively, completion of
these aims will demonstrate a role for the X chromosome in alcohol consumption and determine
which X chromosome genes that escape inactivation in the brain are regulated by alcohol
exposure. Further, we will identify GPCR regulation through Gprasp1 as a mediator of sex
differences in alcohol drinking behaviors. These studies will be the first mechanistic
demonstration of how sex chromosome complement influences vulnerability to alcohol.
Additionally, the proposed work and future related studies have a high likelihood of revealing
multiple targets with potential therapeutic efficacy for problematic drinking behaviors in men and
women.

Public health relevance
PUBLIC HEALTH RELEVANCE: Sex differences in vulnerability to alcohol suggest that alcohol drinking behaviors are influenced by different mechanisms in males and females. This project will use mouse models of alcohol consumption to investigate the contribution of X chromosome genes to drinking behaviors. Interactions with gonadal sex and alcohol exposure will also be explored. Understanding the neural mechanisms that drive differences in alcohol consumption will inform future therapies and treatments for Alcohol Use Disorder.